Research Support for Biomedical Careers at CCNY

The RISE program at CCNY supports undergraduate, masters and doctoral students. Since the previous funding period we have made significant progress in graduating undergraduates and masters students who entered doctoral programs after graduation. Graduation of doctoral students in a timely manner and job placement of the graduates remains a strong part of the RISE program. We believe that the progress in promoting of students into doctoral programs reflects a more stringent candidate selection process to screen out students who are already committed to medical careers or careers in other fields unrelated to biomedical research. For this reason strengthening the processes of candidate selection and advisement is one of the cornerstones of the RISE program in the present proposal. We will also institute a more proactive approach to candidate recruitment than has been true before. As in the past, students will be placed in laboratories at CCNY where they will carry out research projects under the mentorship of faculty in the departments of Chemistry, Biochemistry, Biology, Physics and Earth Science. However, in the next funding period students will have access to a greatly enhanced pool of mentors owing to a recent initiative by the City University of New York to develop infrastructure in the sciences, particularly in the rapidly expanding area of structural biology. Students who choose to work on projects in structural biology will have access to state-of-the-art instrumentation for structural analyses of biomolecules at the newly constructed New York Structural Biology Center. In addition, City College has recently established a partnership with Memorial Sloan Kettering Cancer Center that has created new opportunities for students to gain hands-on experience in cancer research at an internationally recognized cancer center. In conjunction with the partnership, City College has developed new courses in cancer biology and biotechnology that will spur greater awareness of, and interest in, cancer research. Among these is a unique course in social marketing that involves students in direct interaction with the minority community in Harlem to address issues of health disparities relating to cancer incidence and prevention. Since RISE is a minority serving program we anticipate that this will allow students to connect to the field in a more personal way. We anticipate that this will also open a new area of behavioral research that can be incorporated as a regular part of the RISE program in the future.

Public health relevance
Cancer, and many other diseases disproportionately affect minority populations which results in disparities with regard to both disease incidence and treatment outcomes. The RISE program helps to address these health disparities by training minority scientists and promoting their entry into careers in biomedical research.